Molecular Basis and Regulatory Mechanisms of Exosome Secretion

ABSTRACT
Exosomes are small extracellular vesicles secreted by cells. Exosomes carry bioactive molecules such as
signaling proteins and mRNAs, and potently affect the pathophysiology of their recipient cells. The project funded
by my R35 grant “Molecular Basis and Regulatory Mechanisms of Exosome Secretion” (R35 GM141832) aims
to understanding the molecular mechanisms that control the biogenesis and secretion of exosomes, and the
regulation of exosome biogenesis by oncogenic signaling. Due to the small size (30-120 nm in diameter) of
exosomes, a nanoparticle tracking analysis (NTA) equipment is essential for the proposed study. The NTA
equipment carries out functions ranging from quantification of exosome number, measuring exosome diameters,
to fluorescence-based cargo labeling and exosome sub-population identification. Without these basic exosome
characterizations, most of our proposed experiments cannot be carried out.In this proposal, I apply for
Administrative Supplements for Equipment fund (NOT-GM-22-017) for the purchase of a ZetaView® x30 dual
laser multiple parameter NTA device to replace our broken equipment, NanoSight N300. We plan to purchase a
ZetaView®x30 from Particle Metrix, Inc. rather than the NanoSight NS300 from Malvin, Inc. because
ZetaView®x30 is a leading NTA equipment in the market with features meeting our research needs, whereas
the old NanoSight NS300 system has a number of deficiencies revealed over these years. In fact, ZetaView
system is the only NTA device that allow us to characterize exosomes with precision, and is indispensable for
the accomplishment of the goals proposed in the parent R35 grant.

Public health relevance
PROJECT NARRATIVE: Exosomes play an important role in many pathophysiological processes such as neurodegeneration and cancer immune suppression. Studying the molecular basis and regulatory mechanisms of exosome trafficking will help us understand how cancer cells use exosomes for their progression. The study will bridge basic exosome cell biology and cancer biology. A basic nanoparticle tracking analyzer (NTA) carries out functions ranging from quantification of exosome number, measuring exosome diameters, to fluorescence-based cargo labeling and exosome sub-population identification, and is an essential tool for our study of the biogenesis, secretion and function of exosomes proposed in my R35 grant.